Probing NADase function of bacterial Toll/interleukin-1 receptor (TIR) proteins: Starting with a CURE (Course-based Undergraduate Research Experience)

Project Summary
The growing threat of antimicrobial resistance underlies the need for novel therapeutics that target specific
bacterial virulence mechanisms. Bacterial Toll/interleukin-1 receptor (TIR) domain-containing proteins were
originally characterized based on their roles in immune evasion. Early reports demonstrated the ability of
bacterial TIRs to interact with TIR signaling domains in Toll-like receptor (TLR) signaling pathways and block
downstream innate immune responses. Subsequently, bacterial TIRs were found to hydrolyze nicotinamide
adenine dinucleotide (NAD+), a central player in cellular metabolism. The significance of the NADase activity of
bacterial TIRs for bacterial function and survival is not clear, and it also is not known whether NADase activity
plays a role in bacterial TIR interference with host innate immune responses. We hypothesize that bacterial TIR
NADase activity alters metabolic and signaling responses within both bacteria and host cells to contribute to
bacterial virulence and interference with host immune responses. To test this, we will 1) determine the effects of
TcpC NADase activity on bacterial survival within model hosts, 2) identify novel host molecular pathways
targeted by TcpC, and 3) develop course-based undergraduate research experiences (CUREs) for analysis of
model host responses to TcpC and its NADase activity. This project will provide research experiences for a
diverse group of students and will generate research findings that will inform development of therapeutics that
can regulate growth and survival of bacteria, including pathogenic species, or can mimic the functions of bacterial
TIRs to modulate immune responses for the treatment of immune disorders.

Public health relevance
Project Narrative This project aims to characterize the enzymatic activities of bacterial TIR domain-containing proteins and their effects on bacterial virulence. Increased understanding of these mechanisms will inform development of therapeutics targeted at bacterial virulence mechanisms and regulation of innate immune processes. Furthermore, the project will fulfill the mission of the SuRE program by supporting the investigator in development of a robust research program that will engage a diverse group of undergraduate and masters-level graduate students to promote their readiness for post-graduate education and careers in the biomedical workforce.